Social-Ecological and Individual Determinants of the Course of Suicidal Ideation & Attempt among African Americans from Early Adolescence toYoung Adulthood

Suicide among Black youth has increased rapidly over the last two decades, reaching unprecedented levels.
While there have been substantive gains in knowledge related to the etiology of suicide ideation and behaviors
(SIB), most of this work has included predominantly White samples or have been cross-sectional or short-term
longitudinal studies. Less is known about the course of SIB during the adolescent and emerging adult years, and
malleable individual-specific and social ecological precursors and correlates associated with this course, among
low-income, urban Black youth. Such work is vital to informing developmentally-sensitive preventions and
interventions aimed at mitigating this major public health problem. The proposed R01 application aims to address
the aforementioned limitations by leveraging data collected among Black youth (N = 630) drawn from Baltimore
City over a 20-year period spanning the critical developmental windows of adolescence and emerging adulthood,
during which SIB often emerges. Data on mental health, academic and social competence, and life events have
been collected annually during early childhood (i.e., ages 6-8), adolescence (i.e., 12-18) and emerging adulthood
(i.e., 19-26). In addition, SIB, substance use and social ecological constructs (i.e., life events, racial
discrimination, neighborhood characteristics, and social support) have been measured during adolescence and
emerging adulthood. Specific aims of the study include: (Aim 1) to identify trajectories of SIB across adolescence
and young adulthood, and whether SIB trajectories during adolescence are associated with SIB trajectories in
emerging adulthood; and (Aim 2) to determine risk and protective individual-specific and environmental factors
during the early childhood, adolescent, and emerging adult years that are associated with SIB trajectories during
adolescence and emerging adulthood. We also plan to explore whether the identified risk and protective
longitudinal factors in Aim 2 influence the transition or changes in SIB trajectory membership from adolescence
to emerging adulthood. Determining salient factors associated with SIB continuity during adolescence and
emerging adulthood may inform the identification of pathways that could be promoted or interrupted, which may
have long-term implications for SIB across the life course. The investigative team brings together expertise in
the etiology and prevention of SIB among Black youth, prevention science, mental health and substance use of
adolescent and adult populations, and longitudinal latent variable modeling; thus, we are extremely well-
positioned to accomplish the study aims. This study directly responds to recommendations offered in the
Congressional Black Caucus’ Ring the Alarm report as it seeks to: 1) identify subgroups of Black youth at
increased risk for SIB across the lifespan; 2) determine risk and protective factors that are amenable to early
intervention; and 3) examine non-psychiatric factors (e.g., social and structural determinants) associated with
SIB course, which if found to be significantly related to SIB, might be the focus of targeted upstream suicide
preventions among Black youth.

Public health relevance
Leveraging 20 years of data collected annually from ages 6-26 among a low-income, underserved sample of Black youth, the current study will map the course of suicide ideation and behaviors (SIB) during adolescence and emerging adulthood, and will unveil critical risk and protective individual- and environmental factors associated with SIB course. Findings from the current study may inform etiological models of SIB in this vulnerable population and yield actionable knowledge regarding developmentally-relevant intervention targets to curb SIB among Black youth across the life course.